Experimental - Theoretical Studies of Cochlear Mechanisms

DESCRIPTION (provided by applicant): Based on its strategic location, the tectorial membrane (TM) has long been believed to play an essential role in hearing, but the cochlear mechanisms remain unclear. We propose research to improve our understanding of the functional role of the TM in determining (1) the remarkable properties of normal hearing - including its exquisite sensitivity and frequency selectivity - as well as (2) the hearing loss associated with genetic mutations of the TM and other cochlear pathologies. The proposed research is organized in three related aims. Aim 1: We propose to measure dynamic properties of the TM to determine the molecular origin of physiologically important properties such as shearing stiffness and loss moduli, charge density and associated electrokinetic behaviors, and traveling waves of the TM. Aim 2: We propose to measure the effects of genetic manipulations on TM dynamic properties. Measurement of TM waves, longitudinal coupling, charge density and electrokinetics of TMs in genetically modified mice will provide a framework for understanding the physical basis of the corresponding hearing disorders. Aim 3: We propose to measure interactions of the TM with other cochlear structures in an isolated, intact cochlea. We will measure relative motions of the TM and hair bundles in response to stapes motion. These measurements will provide direct tests of the TM's role in stimulating the hair bundles and spreading excitation along the cochlear spiral. Results from these three aims will increase our understanding of the cochlear mechanisms that underlie both normal and abnormal hearing. This knowledge has important practical applications for the delineation of inner-ear disorders (and concomitant suggestions for treatment) and for the design of speech-processing devices such as cochlear implants, hearing aids, and speech-recognition systems. PUBLIC HEALTH RELEVANCE: Our ability to communicate with each other and to navigate through acoustically rich environments depends on the detection and analysis of sounds by the inner ear. Genetic studies have shown that the tectorial membrane plays a key role in this analysis, but little is known about the underlying mechanisms. The proposed research to clarify these mechanisms will improve our understanding of both normal and impaired hearing and will be important for the design of speech-processing devices such as cochlear implants, hearing aids, and speech-communication and speech-recognition systems.

Public health relevance
Our ability to communicate with each other and to navigate through acoustically rich environments depends on the detection and analysis of sounds by the inner ear. Genetic studies have shown that the tectorial membrane plays a key role in this analysis, but little is known about the underlying mechanisms. The proposed research to clarify these mechanisms will improve our understanding of both normal and impaired hearing and will be important for the design of speech-processing devices such as cochlear implants, hearing aids, and speech-communication and speech-recognition systems.